Hawaii Interdisciplinary Mentored Career Development in HIV Co-Morbidities

ABSTRACT
University of Hawaii
Contact MPI: Cecilia Shikuma, MD
This proposal to establish the Hawaii Mentored Institutional Career Development Program in HIV-Related
Heart, Lung, Blood and Sleep (HLBS) Co-Morbidity Research in response to RFA-HL-18-006 is submitted by
the Hawaii Center for AIDS (HICFA) at the John A. Burns School of Medicine (JABSOM), University of Hawaii
at Manoa (UHM). We propose to groom the next generation of nationally competitive investigators in the field
of HIV HLBS research by building on HICFA's growing research strengths in HIV-related HLBS co-morbidities
research and our HIV clinical, translational and laboratory science infrastructure, and strengthen the
infrastructure by establishing mutually beneficial collaborative relationships with other programs and
institutions. This includes internal collaborations with various departments within JABSOM as well as with our
Center for Cardiovascular Research and its T32 program and our school's Cardiology Fellowship Program.
We propose an overall K12 structure with multi-PI leadership involving a HIV clinical researcher, a laboratory
HIV immunologist and a Cardiovascular researcher and an Executive Committee and an Administrative
Assistant to assist in implementation of a mentored institutional career development program with assistance
of an Advisory Committee. Year one of the grant will be spent in planning the details of this structure.
Subsequently a minimum of 3 and maximum of 5 junior scholars will be provided with up to 3 years of
mentored support towards research independence in the research area of HIV HLBS co-morbidities.

Public health relevance
PROJECT NARRATIVE University of Hawaii Contact MPI: Cecilia Shikuma, MD This grant will establish the Hawaii Mentored Institutional Career Development Program in HIV-related heart, lung, blood and sleep co-morbidity research. The intent of this grant is to enhance the number of nationally competitive investigators conducting research in this area of HIV research.